Enhancing Drug Discovery Research by Free Energy Modeling

PROJECT SUMMARY/ABSTRACT
Accurate computational binding free energy models that estimate the dissociation constants of protein-
ligand complexes by representing the motion of compounds and their cellular targets at atomic
resolution are increasingly contributing to the discovery of drugs. However, due to their limited range
of applicability, perceived barriers to entry, and scarcity of computational modelers with sufficient
expertise to make good use of them, free energy models of protein-drug binding are still not widely
adopted, especially in academic settings. The project addresses the need to widen access, build
expertise, and extend binding free energy computational models for a broader pool of drug discovery
applications in academic and industrial settings. It does so while expanding the research capacity at
Brooklyn College by providing molecular modeling support to experimental projects in the health
sciences and offering meaningful educational and research opportunities to our students.
The PI’s lab has developed the Alchemical Transfer Method (ATM) for binding free energy
estimation that incorporates the best science and simplifications afforded by the next generation of
algorithms and circumvents many of the shortcomings of traditional approaches. ATM supports diverse
ligand libraries and will be extended to treat bridging water molecules, metal ions, and conformational
changes induced by ligand binding, all critical and outstanding problem areas for binding free energy
models. Through partnerships with local academic labs, the project will investigate viral, cancer, and
drug addiction targets enabled by these novel technologies.
Molecular modeling tools are only as good as their ability to give insights into the molecular
basis of disease. Building on solid partnerships with experimental laboratories, the project will promote
the complementary use of molecular modeling in biochemical and drug discovery research through
interdisciplinary student research experiences. It will build upon the successful ICompute
Interdisciplinary Undergraduate Research initiative at Brooklyn College to bring computational and
experimental laboratories together and nurture the next generation of researchers.

Public health relevance
PROJECT NARRATIVE Computational models of molecular binding are increasingly contributing to the discovery of drugs against viral infections, cancer, and other diseases. Molecular simulations on powerful parallel computational devices complement laboratory experiments by giving information about the interactions and motion of individual atoms. The project will develop more accurate computational models to predict the strength of binding between drug molecules and target proteins in the cell.